CHOICES-TEEN: Efficacy of a Bundled Risk Reduction Intervention for Juvenile Justice Females

Project Summary Abstract
Latina adolescents involved in the juvenile justice system experience heightened
sexual health disparities compared with non-involved Latina adolescent females.
Sexual health risks of concern include unplanned pregnancy, less frequent condom
use and higher HIV/STI risk, and the interaction of these risks with substance use.
Given the rapid national growth of Latinx adolescents in the U.S., addressing these
health disparities is critical. Currently, there is a dearth of gender sensitive, culturally
informed interventions targeting risky sexual behavior among Latina adolescents who
are overrepresented in the juvenile justice system. Better understanding of the
intersection of substance use, sexual risk behaviors, and interpersonal violence for this
population is critical to inform future prevention research. This proposed supplement is
a natural extension of the CHOICES-Teen parent grant (R01 DA050670), as it explores
the intersection of primary study outcome variables (substance-exposed pregnancy
risk, pregnancy risk, and HIV/STI risk) and interpersonal dating violence data currently
being collected by the parent grant and proposes qualitative interviews with study
participants after completion of the study at 9 months. Findings from this proposed
research will help inform future culturally adapted prevention interventions for Latina
women by elucidating a better understanding of interpersonal dating violence in
younger adolescent women, as well as the ways such violence may be related to
substance use, sexual health risk behavior, the processes of change and other TTM
variables, and how these relationships may differ by race/ethnicity.

Public health relevance
Project Narrative In response to PA-21-071: Research Supplement to Promote Diversity in Health-Related Research, this proposed supplement is a logical extension of the CHOICES-Teen parent grant (R01 DA050670) that will explore the intersection of primary study outcome variables (substance-exposed pregnancy risk, pregnancy risk, and HIV/STI risk) and interpersonal dating violence data collected from adolescent females involved in the juvenile justice system. Findings will inform culturally relevant gender sensitive prevention programming. Completion of proposed research objectives and training plan will support Avellaneda’s transition to independent research investigator with expertise in the intersection of substance use, interpersonal violence and sexual health with young women.